Genetic variation underlying innate lymphoid cell phenotypes across hosts

Project Summary
Maintenance of gut epithelial homeostasis requires signals from a specialized set of RORγt+
innate lymphoid cells (ILCs) that reside in mucosa. RORγt+ ILCs directly regulate the gut
barrier by secreting cytokines that activate epithelial host defense mechanisms and reinforce
gut barrier integrity. Among the RORγt+ ILCs, there exists a set of phenotypically diverse cells
characterized by distinct patterns of cytokine secretion, transcription factor expression, and
physical distribution. Although a comprehensive understanding of the diversity of RORγt+ ILCs
is required to mechanistically determine how to manipulate these cells, the full spectrum of
ILCs remains to be examined. Our objective is to characterize the diversity of ILC subtypes,
and define their development, function, and spatial regulation. Our long-term goal is to exploit
mechanisms that control distinct innate lymphocyte subtypes to selectively manipulate these
cells in vivo and restore mucosal homeostasis after intestinal dysregulation. We identified a
specialized population of RORγt+T-bet+ ILCs that exhibited distinct patterns of expression of
the chemokine receptor CCR6 compared to related ILCs. We also found that this chemokine
receptor expression is associated with enhanced secretion of epithelial cell-active cytokines
and was strongly regulated by genetic variation. We hypothesize that genetic variation in
mouse strains results in distinct patterns of spatially distributed ILCs in tissue, which alter the
capacity of RORγt+ ILCs to secrete mucosal cytokines. In Aim 1, we will investigate the
developmental pathway of these newly described ILCs and identify genetic mechanisms
regulating their expression of CCR6. In Aim 2, we will determine the impact of CCR6 on
tissue localization of natural ILCs and their contribution to barrier immunity. These studies will
provide insight into how diverse configurations of innate immune cells caused by genetic
variation can shape underlying mucosal fitness.

Public health relevance
Project Narrative The intestinal epithelial barrier is regulated by cytokines produced by innate lymphoid cells. This research seeks to define genetic regulatory elements that generate diversity in innate lymphoid cells among distinct hosts. We will investigate how genetic variation affects the spatial organization of these cells within tissue and immune function at the intestinal barrier.